Spatial Science Approaches to Enhance Gun Violence Surveillance and RelatedDeterminants

Project Summary/Abstract
Gun violence in the United States continues to be a persistent and growing public health threat with over 100
fatalities per day. Furthermore, gun violence is most pervasive in disadvantaged neighborhoods characterized
by disparities in race/ethnicity, poverty, educational attainment, among many other social determinants of health
(SDoH). The SDoH are highly dependent on where individuals live, work, and recreate. Therefore, the inherent
nexus between health and place should be explicitly considered when identifying, quantifying, and discussing
gun violence, which is one of the main contributions of this proposed project. My long-term career goal is to
become a leading interdisciplinary researcher in firearm injury and mortality prevention, investigating the spatial,
human behavioral, social, and environmental determinants of firearm risk and mortality. My K18 proposal
includes a career development plan and training activities that will expand my current expertise in spatial science
with advanced training in gun violence and health policy to complement my growing experience in these domains.
My mentoring team possess the expertise and interdisciplinary experience necessary to facilitate my training
goals and transition to an independent investigator in the intersection of gun violence and spatial science. My
proposed research, which leverages publicly available criminology, Census, and SDoH variables, will (1) develop
an analytical approach to detect emerging spatial-temporal clusters of gun violence incidents at the
neighborhood and weekly levels in Washington, D.C.; (2) develop a spatial-temporal regression model to
examine the impact of the social determinants of health (SDoH) and other place-based factors on gun violence
risk; and (3) examine potential spatial-temporal associations between gun violence incidents and alcohol outlet
access and hours of operation. Aim 1 hypothesizes that I will detect anomalous clusters of gun violence events
throughout the study area and period after adjusting for related covariates and baseline conditions. Aim 2
hypothesizes that (a) various disparities among the SDoH are strongly associated with gun violence risk and (b)
neighborhoods near high-risk areas will exhibit a spatial spillover effect. Aim 3 hypothesizes that (a) high-risk
areas of gun violence incidents can partly be explained by alcohol outlet access and (b) outlets with longer and
later operating hours significantly increase gun violence risk. The outcomes and frameworks from this research
on gun violence and its spatial and temporal determinants will inform other research across the United States,
inform policymakers, and provide the foundation for larger funded project applications (e.g., R01). Overall, this
project can improve our understanding of the SDoH, segregation, spatial and temporal interaction, and
relationships with other factors that are necessary to improve violence reduction programs and policy. My
mentoring team and I will leverage connections with programs and officials in Washington, D.C. to facilitate the
dissemination of key results and improved gun violence surveillance tools.

Public health relevance
Project Narrative Little is known about how the social determinants of health (SDoH), the arrangement and quality of neighborhoods alcohol outlet hours of operation influence gun violence events and risk. This project will utilize cutting-edge spatial science approaches to understand the spatial and temporal dynamics of gun violence in Washington, D.C. at the neighborhood level from 2014-present. Results from this research could improve our understanding of the SDoH, segregation, spatial and temporal interaction, and relationships with other factors that are necessary to improve gun violence reduction programs and policy.